Advancing Hormone Therapy for Endometrial Cancer

PROJECT SUMMARY – OVERALL Advancing Hormone Therapy for Endometrial Cancer
Uterine endometrial cancer (EC) is the only cancer with significantly worse outcomes today compared to 50
years ago. There is an urgent need to improve clinical management of EC patients and patients with pre-
cancerous atypical endometrial hyperplasia (AEH) through the development of safer and more effective
prevention and treatment strategies. This multi-institutional P01 application seeks to improve outcomes for EC-
AEH patients by identifying improved strategies to: 1) prevent the transition of AEH to EC, 2) prevent the
progression of EC after initial treatment, and 3) prevent treatment-associated breast cancer. First used in the
1970s, progestins (synthetic compounds that target progesterone receptor) are still the only FDA-approved
pharmacological agent for early-stage/low-grade EC treatment, representing the majority of EC tumors. Despite
being a relatively safe and effective clinical tool, progestin use is very limited. We propose that progestins are
under-utilized for three reasons: 1) despite FDA approval of >20 progestins for contraception and hormone
replacement therapy, they have not been systematically evaluated for prevention and treatment of EC-AEH, and
as a result the most effective progestin is not known; 2) there are no clinical or molecular biomarkers that predict
progestin efficacy much less the use of specific progestins; and 3) the safety of long-term progestin use has
been called into question by multiple clinical studies linking progestin use to increased breast cancer risk. The
ideal progestin would be at least or more effective than the current standard of care in EC-AEH, but with an
improved profile for cancer initiation and progression in the breast. Accordingly, the goals of this collaborative
project are to identify the ideal progestin(s) for EC-AEH prevention and treatment, and to use them more
effectively by understanding their mechanism and identifying patients who will benefit from their use.
To achieve our goals, we have assembled an exceptional team of investigators with extensive expertise in
endometrial cancer, breast cancer, and steroid hormone signaling to systematically evaluate progestin efficacy
on a phenotypic (Project 1), molecular (Project 2), and clinical (Project 4) level, while counterbalancing efficacy
with the potential for unwanted effects in the breast (Project 3). To aid in the success of these Projects, the
Administrative Core will provide critical organizational and administrative support to all Projects, the Biospecimen
Core will provide important sample and pathology services to all Projects, and the Data Analysis Core will provide
biostatistics and bioinformatics support essential for all Projects. Our understanding of the mechanism of action
and the effectiveness of progestins lags far behind their extensive clinical use in women. By working as a
collaborative team, we hope to establish a new paradigm for prevention and treatment of EC-AEH by identifying
the optimal progestin(s) to be used in clinical practice, as well as which patients are most likely to derive benefit.
The four Projects and three Cores are highly synergistic, supporting an in-depth analysis of progestin action
and clinical effectiveness within the same program.

Public health relevance
PROJECT NARRATIVE – Advancing Hormone Therapy for Endometrial Cancer Incidence and mortality for uterine endometrial cancer are on the rise worldwide, and hormonal therapy with progestins is currently the only approved non-surgical approach for treating early stage endometrial cancer. However, the use of progestin is limited due to a lack of systematic evaluation across the many progestins in clinical use, a lack of knowledge about which patients are likely to benefit from progestin therapy, and the potential for increased breast cancer risk. The program project will address these issues through a multi- disciplinary approach that spans basic science to a clinical trial, with the goal of advancing hormone therapy for endometrial cancer prevention and treatment.